Mechanisms of CD8+ T cell-induced Innate Immune Activation

PROJECT SUMMARY
CD8+ T cells play a pivotal role in protective immune responses against intracellular pathogens and cancer
progression. Most CD8+ T cells activated during a primary immune response will contract and die, however, a
small percentage will persist and form long-lived memory populations (CD8+ Tmem). CD8+ Tmem can occupy
various anatomical niches and rapidly respond to subsequent antigen encounters, leading to effective secondary
responses. Despite the importance of cytotoxic functions, much work has shed light on the ability of CD8+ T cells
to confer protection from pathogens in the absence of cytotoxic machinery. However, the underlying mechanisms
responsible for such protection remain ill-defined. Our lab has demonstrated that memory CD4+ T cells are able
to engage innate immune cells and drive inflammatory responses, a process dependent on MHC-TCR and
Tumor Necrosis Factor Superfamily (TNFSF) ligand-receptor interactions. Here, ligands expressed by memory
CD4+ T cells engage receptors on myeloid cells, leading to NFκB-dependent cytokine production. We have
generated preliminary data suggesting that CD8+ Tmem, but not effector CD8+ T cells, can also activate myeloid
proinflammatory responses during cognate interactions, albeit through distinct mechanisms from those of
memory CD4+ T cells. CD8+ T cell-induced myeloid proinflammatory responses result in production of several
key innate cytokines, including IL-1β and IL-6, both of which are critical to anti-microbial responses. Additionally,
antigen-presenting cells cultured with CD8+ Tmem display increased transcript levels of Type I Interferons (IFN)
and Interferon-Stimulated Genes (ISGs), both of which are critical to antiviral and anti-cancer responses. Similar
increases in ISG responses were also observed in vivo within various tissues after selective reactivation of CD8+
Tmem. These data suggest an evolutionary mechanism wherein reactivation of CD8+ Tmem results not only in rapid
effector function and cell killing, but also innate activation and induction of a systemic anti-microbial response.
The objective of this proposal is to test the overall hypothesis that induction of innate inflammation is a critical,
non-canonical function of CD8+ Tmem necessary for optimal immune responses. In Aim 1, we plan to discern the
molecular mechanisms underlying CD8+ Tmem-induced innate inflammatory responses and the importance of this
axis in microbial immunity. We will identify key ligand-receptor interactions necessary for proinflammatory
cytokine production and initiation of Type I IFN responses. In Aim 2, we will investigate the mechanisms that
promote or attenuate CD8+ T cell-induced innate responses, particularly focusing on the role of immune
checkpoint molecule signaling during cognate interactions. Successful completion of these aims will uncover a
novel function of CD8+ T cells in modulation of innate inflammatory responses, with profound implications for
therapeutic development.

Public health relevance
PROJECT NARRATIVE CD8+ T cells are a critical component of the adaptive immune system and are pivotal in combating intracellular infections and cancer. While the canonical cytotoxic function of CD8+ T cells is well established, the ability of these cells to influence and shape immune responses through alternative mechanisms requires further investigation. This proposal will investigate the molecular mechanisms, and functional outcomes, of innate immune activation by CD8+ T cells, with implications for novel therapeutic development relevant across several disease states.